TCI Early Career Cancer Clinical Investigator Award

Deborah Doroshow, MD, PhD is a medical oncologist and clinical investigator at the Tisch Cancer Institute,
Icahn School of Medicine at Mount Sinai who specializes in thoracic oncology and histology-agnostic early
phase drug development. This application to the Early Career Cancer Clinical Investigator Award (ECIA) P30
Administrative Supplement (ECIA) describes Dr. Doroshow’s intent to expand her clinical trial research and
leadership activities in 1) the Early Therapeutics Clinical Trials Network (ETCTN), 2) the Southwest Oncology
Group (SWOG), and 3) the Division of Hematology and Oncology at Mount Sinai. In the ETCTN, she will
become principal investigator of the existing Mount Sinai Early Drug Development Opportunity (EDDOP) grant.
In that role, she will collaborate with junior faculty and hematology/oncology fellows to open existing ETCTN
early phase clinical trials and will provide guidance and support regarding the submission of novel study
concepts. As an individual investigator, she will submit at least one original early phase study concept to CTEP
for consideration. As a member of the SWOG lung committee, Dr. Doroshow will co-chair a LUNG MAP
substudy of trastuzumab deruxtecan in patients with advanced ERBB2 amplified NSCLC. She will join the
locally advanced lung cancer committee and participate in ongoing efforts to analyze genomic characteristics
of patient participants in previous and ongoing SWOG thoracic oncology trials. In the Tisch Cancer Institute
and Division of Hematology and Medical Oncology, Dr. Doroshow will serve on the Data Safety Monitoring
Committee and continue to lead the Investigator Initiated Trial (IIT) incubator workshops and serve on the IIT
review committee. Her research and institutional work on improving the diversity of clinical trial participants will
influence efforts in these three domains.

Public health relevance
The work described in this application has the fundamental goal of supporting cancer clinical research in a broad patient population and is thus of direct relevance to the National Cancer Institute’s goal of advancing scientific knowledge and helping all people to live longer, healthier lives. Dr. Doroshow’s work as EDDOP PI and LUNG MAP substudy co-chair will increase Mount Sinai participation in ETCTN and NCTN early phase clinical trials and offer more patients the opportunity to receive potentially effective novel therapies for advanced cancers. Her leadership in these areas will also be of benefit to trainees and junior investigators, helping them to develop patient-centered, innovative clinical trial portfolios.